NEUROPATHOLOGY CORE

The Neuropathology Core of this ADCC has the function to provide post-mortem diagnoses on patients and control subjects enrolled in the clinical core and on other well documented AD cases and controls, who are obtained via our satellite at the Sun Health Research Institute. Also part of this NP core and unchanged from the prior grant period, is a Morphometric Component performed at the Institute for Basic Research (IBR) on Staten Island. The Morphometric Component of this core is essential for the careful characterization of AD and control brain tissue in terms of the volume of different brain structures, number of neurons, glial cells, amyloid load and neurons with neurofibrillary change. This information can then be used for precise clinico-pathological correlation. The Specific Aims of this Neuropathology Core are: 1. To conduct thorough postmortem examinations on ADCC patients (N=15-20/yr from NYU) and an average of 55/yr from the Sun Health Research Institute (average post-mortem time 2.83 hr.). 2. To maintain a bank of unfixed frozen and fixed tissue from the ADCC control and patients with AD or other dementing neurodegenerative conditions;as well as to bank plasma and CSF from these patients. 3. To provide tissue from control brains, AD and other neurodegenerative conditions to AD researchers within and outside this ADCC in order to augment clinical and basic research on AD. 4. To conduct morphometric studies on AD to establish better clinical neuropathological correlation, in particular to document the progression of the earlier stages of AD pathology. 5. To conduct anatomic and pathologic correlation with in vivo and post mortem MR scans in collaboration with the Neuroimaging Core. 6. To collaborate in the research efforts of the other cores and projects of the ADCC, as well as providing advice and facilities to investigators within and outside the ADCC.